Extracellular vesicles from parasite and host in leishmaniasis

Leishmaniasis refers to a constellation of disease syndromes caused by the Leishmania spp.
protozoa. Leishmaniasis affects persons residing in endemic regions, including the sites of recent
and ongoing US military activities in the Middle East. Common forms of leishmaniasis include visceral
leishmaniasis (VL) caused by Leishmania infantum or L. donovani, or cutaneous leishmaniasis (CL),
often due to L. major or L. tropica in the Middle East and northern Africa. A common feature of the
different forms of leishmaniasis is their propensity to cause asymptomatic infections, particularly in
healthy hosts. The ratio of asymptomatic to symptomatic leishmaniasis varies from 6.5:1 in to >100:1
in different endemic regions. Due to the poor ability to recover parasites in culture and imprecise
markers for infection, diagnosis of asymptomatic infections can be elusive. The mechanisms and the
consequences of these occult infections are largely unknown.
Methods to recognize asymptomatic leishmaniasis have improved, leading to a recent report
that nearly 20% of soldiers deployed to endemic regions of Iraq during 2002-2011 have evidence of
ongoing L. infantum infection in their bloodstream. Leishmaniasis is a disease associated with
chronic inflammation, and we do not know the consequences of long-term asymptomatic infection with
this protozoan. Furthermore, asymptomatically infected soldiers are at risk for developing
symptomatic disease if immunocompromise occurs in later years.
All eukaryotic cells release extracellular vesicles (EVs) into their environment. The subset of
EVs called exosomes are known to transmit bioactive proteins, microRNAs, metabolic enzymes and
lipids between cells or throughout the bloodstream. Our preliminary studies show that exosomes from
L. infantum induce an inflammatory state in human cells and in murine skin, which phenocopies the
inflammatory state induced by the infectious parasite. This finding led us to hypothesize that at least
some of the inflammatory responses induced during leishmaniasis are caused by exosomes released
from intact parasites or from leishmania-infected cells. Aims of the current application are: ‘
Aim #1: To document the differences in protein and miRNA content of EVs released by different
species of Leishmania, or by naïve or Leishmania-exposed myeloid cells.
Aim #2: To query to what extend the components of EVs are responsible for host inflammatory
responses in murine models of leishmaniasis, both locally and systemically.
Aim #3: To document differences between EVs circulating in serum or released in urine of healthy
humans or people with asymptomatic or symptomatic Leishmania spp. infections.
Through these studies we will address the hypothesis that Leishmania infection causes the release of
EVs whose contents induce many of the systemic inflammatory responses associated with
Leishmania spp. infections. We hope that these findings will inspire the design of novel therapeutic
and/or diagnostic approaches to leishmaniasis.

Public health relevance
Leishmaniasis is a diverse set of parasitic syndromes that affect individuals living in the many endemic regions. These include sites of ongoing US military operations in the Middle East and Central America. All forms of the disease are characterized by imbalanced immune response with excessive inflammation and suppressed microbicidal activity against these pathogens. Advances in diagnostic measures led to the recent recognition that a large proportion of US military personnel stationed in endemic regions of Iraq and Afghanistan in 2003-2011 have ongoing asymptomatic infection with L. infantum, which can cause a potentially fatal visceral form of disease. The current application is focused on detecting pathogenic mechanisms through which L. infantum might be affecting the health of asymptomatically infected hosts, and more sensitive measures through which such infections might be recognized.